BONE AND TOOTH MATRIX BIOCHEMISTRY AND METABOLISM

The extracellular matrix proteins of the bones and teeth are key elements in the structure and metabolism of these tissues. The goal of this project is to study matrix proteins specific to each mineralizing skeletal tissue in order to understand their molecular structure and biological function. Analytical procedures (polyacrylamide gel electrophoresis, immunoblotting, specific; dye-binging, RIA, ELISA, etc.) have been developed to quantitate the levels of noncollagenous proteins in bone including osteonectin, bone sialoprotein, osteopontin, bone proteoglycans BGN and DCN, dentin phosphophoryn and the N- propeptide and C-propeptide of type 1(I) collagen in (a) surgical specimens of bony tissue and (b) serum (osteonectin). Changes in the noncollagenous protein profile with age and variety of bone (and tooth) diseases have been observed in man and several animal models. We have been highly successful at producing antisera against, synthetic peptides for all of the human bone noncollagenous proteins. These antisera have proven useful in immuno precipitation studies, immunolocalization,l immunodetection and on Western blots. We have successfully cloned and sequence human bone proteoglycans I (biglycan) and II (decorin), sialoprotein (BSP) and two members of the osteopontin family (OPN-L and OPN-2). The human biglycan gene ha$ been cloned and sequenced.